Electronic Cigarettes as a Harm Reduction Strategy Among People with Opioid Use Disorder on Buprenorphine

PROJECT SUMMARY/ABSTRACT
Candidate and career development: I am an Assistant Professor at Clemson University, proposing a K01
career development plan and research plan to prepare me to become an independent clinical research scientist
and leader in developing and implementing innovative and feasible Electronic Cigarette (EC) protocols across
clinical settings to reduce the combustible cigarette (CC) burden among people with opioid use disorder (OUD)
on buprenorphine. This proposal builds on my expertise in nicotine and opioid research and extends it in
important ways. The goal of the career development plan focuses on six skill areas: (1) qualitative methods, (2)
quantitative methods, (3) ecological momentary assessment (EMA), (4) tobacco regulatory science, (5) grant
writing, and (6) leadership skills.
Mentorship team: The proposed mentorship team is truly multidisciplinary, with backgrounds in addiction
medicine, public health, psychology, and biostatistics. Each mentor will contribute distinctive expertise to
facilitate my progression as an independent clinical researcher. All proposed mentors have previous experience
mentoring successful mentees or K awardees, with exceptional records of scientific publications and extramural
grant funding.
Research strategy: Evidence supports the use of EC in reducing the number of cigarettes smoked per day
(CPD) or switching away from CC among adults in the general population. However, people with OUD are
underrepresented in such studies. EC flavor and use frequency may influence switching and reducing CPD in
people without OUD. Adult CC smokers prefer sweet flavors to tobacco flavors, and cooling flavors may further
enhance the sensory experience of sweet flavors. Use of flavored EC, other than tobacco, has been linked to an
increased likelihood of reducing CPD or switching to EC among CC smokers without OUD. To our knowledge,
no study has systematically tested the impact of EC flavor and patterns of EC use on harm reduction milestones
(e.g., CPD reduction, switching) among people with OUD. In a three-group randomized controlled trial (RCT),
exclusive CC users (N=90) with OUD on buprenorphine, who are not interested in quitting, will be recruited
across rural and urban outpatient settings. These participants will receive counseling and be randomly assigned
to receive a 12-week supply of sweet-cooling, sweet non-cooling, or tobacco-flavored EC. Ecological momentary
assessment (EMA) methodology will enable us to examine patterns of EC use associated with important harm
reduction milestones. This K01 aims to offer expertise in advanced quantitative statistics, EMA, qualitative
research, grant writing, and leadership development, alongside a mentored research experience to achieve the
following specific aims: (1)Testing the effect of EC flavors on CPD reduction, switching, and other harm reduction
milestones; (2) Characterizing rates and patterns associated with harm reduction milestones; (3) Identifying
barriers and facilitators in implementing and maintaining the EC protocol.

Public health relevance
PROJECT NARRATIVE This K01 proposal aims to investigate the impact of e-cigarette (EC) flavors and usage patterns on achieving harm reduction milestones. Utilizing the RE-AIM Framework, we will identify barriers and facilitators to implementing and maintaining the EC protocol in both rural and urban settings. The findings will offer preliminary evidence of the harm reduction potential of ECs and provide strategies for implementing and sustaining EC- based harm reduction protocols. If successful and sustainable, these protocols may ultimately reduce tobacco- related morbidity and mortality among individuals with opioid use disorder on buprenorphine.